Mapping the Interactions and Dynamics that Organize Bacteria Cells

Project Summary
Molecular-scale interactions enable subcellular organization, but the current state-of-the-art does not include a
generalizable method for measuring how molecules move and cooperate on the nanometer scale and in real
time within the cell. This gap is particularly striking in bacteria cells. Accordingly, our picture of the organization
of the bacterial cell is incomplete. This proposal aims to understand how cellular components organize—by
scaffolding, aggregation, phase separation, or otherwise—to produce a general model of bacterial cell
organization and ultimately enable us to promote commensal bacteria or fight human disease. Thus, we aim to
measure the positioning, interactions, and motions of molecules in living bacterial cells in different protein
systems implicated in the sub-cellular organization of these cells. This proposal will develop these next-
generation super-resolution tools through three synergistic specific aims: (1) to super-resolve how single-
molecule dynamics vary in space and in time in living bacterial cells; (2) to super-resolve sub-cellular interactions
in space and time in living bacteria cells; and (3) to improve the detection of single molecules in living bacteria
cells. The toolkit that we develop to map molecular motions and interactions will be broadly applicable to the
single-molecule bacteriology community. Furthermore, by focusing on applications in bacterial cell biology, the
tools developed in this project will have a widespread, positive biomedical impact by making accessible long-
term, significant questions in microbial biology.

Public health relevance
Project Narrative Molecular-scale interactions govern cell biology, and super-resolution microscopy has emerged as a powerful tool for attaining nanoscopic maps of the inside of the cell. This work will develop novel super-resolution microscopy tools to characterize the biochemical reactions occurring in bacterial cells in real time. By providing synergistic information—localization maps, interaction maps, and mobility maps—we will investigate broad themes in bacterial cell biology to develop new paradigms for subcellular organization in these small cells.